NIH Administrative Supplement to purchase an Agilent 1260 Infinity II SFC System

Project Summary/Abstract
The efficient and stereoselective preparation of chiral organic molecules is vitally important to the development
of new therapeutic agents. However, despite significant progress, many desirable complex 2D and 3D molecular
scaffolds remain difficult to access or are inefficiently prepared. Consequently, development of new
transformations that provide synthetic chemists with strategic bond disconnections that facilitate de novo
approaches to organic synthesis is of great importance. In addition, such methods should be robust, practical,
allow the preparation of useful amounts of material, and ideally employ readily available starting materials. The
aim of this MIRA grant is the conversion of an NIGMS funded project with a long-term goal that broadly seeks to
develop and exploit new, practical, and efficient stereoselective new technologies for organic synthesis of
molecular scaffolds of biological importance that are otherwise difficult to access, or inefficiently prepared via
current processes. To this end, we are interested in developing transformations that leverage the broad chemical
reactivity of boron-stabilized chemical synthons for complex molecule synthesis. This approach is attractive
because reactions of such intermediates permit novel bond constructions and simultaneous installation of a
synthetically desirable boron moiety. The proposed studies described in this program will further our expanding
studies of catalytic stereoselective C–C bond forming reactions with organoboron reagents. These readily
accessible reagents merge powerful bond forming reactivity with broad synthetic utility, to deliver versatile
organic compounds of notable significance for fragment-based drug discovery. Building off our previous work,
we are developing new catalytic C–C, C–N, and C–X bond forming methods for the synthesis of chiral amines,
alcohols, and aromatic structures, with a particular focus on examples that contain quaternary carbon
stereogenic centers. We envision that chiral metal nucleophiles can be accessed by enantioselective
transmetalation of readily accessible achiral organodiboron reagents. The resultant nucleophilic species can
engage in a number of enantioselective reactions with various C=O, C=N, C–X electrophiles. We also aim to
target the generation and utility of novel boron-functionalized synthons by metal-free Lewis base catalysis for
reactions with electrophiles that are difficult to achieve via transition metal catalysis. Importantly, enantioselective
variants of these unknown reactions will herein be explored. Furthermore, new nucleophilic aromatic substitution
reactions of aromatic and heteroaromatic compounds with organoboron carbon nucleophiles will be developed
that operate under metal-free conditions. Overall, by exploring synthetic reactions of organoborons, these studies
in methods development will introduce new transformations and strategies that will streamline synthetic chemists’
approaches to complex molecules important to biomedical research.

Public health relevance
Simon J. Meek: New Organoboron-Based Methods and Strategies for Organic Synthesis; 5R35GM141558 Research Strategy: A. Summary: The efficient and stereoselective preparation of chiral organic molecules is vitally important to the development of new therapeutic agents. Consequently, development of new transformations that provide synthetic chemists with strategic bond disconnections that facilitate de novo approaches to organic synthesis is imperative. Research under the aegis of this MIRA grant broadly seeks to develop and exploit new, practical, and efficient stereoselective technologies for organic synthesis of molecular scaffolds of biological importance that are otherwise difficult to access or inefficiently prepared via current processes. To this end, we are interested in developing transformations that leverage the broad chemical reactivity of multi-functional chemical synthons for complex molecule synthesis. These readily accessible platforms merge powerful bond forming reactivity with broad synthetic utility, to deliver versatile organic compounds of notable significance for fragment-based drug discovery. Building off our previous work, we are developing new catalytic C–C, C–N, and C–X bond forming methods for the synthesis of chiral amines, alcohols, and aromatic structures, with a particular focus on examples that contain quaternary carbon stereogenic centers. For example, chiral metal nucleophiles can be accessed by enantioselective transmetalation of readily accessible achiral multifunctional reagents. The resultant nucleophilic species can engage in a number of enantioselective reactions with various C=O, C=N, C–X electrophiles, to deliver non-racemic versatile organic compounds of notable significance. Moreover, we are targeting the generation and utility of novel functionalized synthons by metal-free Lewis base catalysis for reactions with electrophiles that are difficult to achieve via transition metal catalysis. Importantly, enantioselective variants of these unknown reactions are being explored. Stereoselective reactions currently under study are shown in Schemes 1 and 2. Scheme 1. Catalytic Stereo- and Site-selective Reactions with New Multifunctional Reagents: A. General Reaction Theme: B. Program: Stereoselective Synthesis with Multifunctional Reagents (chiral) · Representative Example: stereo- FG1 FG2 catalyst chiral R2 NHG controlled R2 NHG NG B(pin) FG3 FG4 catalyst R1 R3 transformation R1 R3 R1 R2 (pin)B R3 B(pin) G = C, O, G simple accessible Complex N, X multifunctional Functionalized high dr, er building blocks products ■ Convergent Stereoselective Complexity Building Reactions Synthons: R1 B(OR)2 R2 α-Boryl carbanion R1 B(OR)2 R2 α-Boryl radical C. Examples of Challenging Molecular Scaffolds · Quaternary Carbons, N Vicinal Stereocenters – Challenging Me H OMe O Me Me Me OH · Chiral Amines H – Common motifs arenol A in drugs HO D. Representative Copper-Catalyzed Enantioselective Synthesis of Tertiary Alcohols and Amines By C–O and C–N Bond Formation: Me ■ Representative Examples: [(pin)B]2HC OH OH R CuOtBu (10.0 mol%) 1 (1.0 equiv) L1 (12.0 mol%) B(pin) B(pin) + Me Me Ph CD3OD (1.05 equiv) Me N THF, -60 °C, 16 h 4 5 N N or N 72% yield, >98% yield, Me O CO2Me 91:9 e.r. 97:3 e.r. CO2Me Ph N B(pin) N H Me nBu 6 62% yield 88:12 e.r. Ar=3,5-Me2C6H3 L1 2 (1.0 equiv) 3 (in situ N–O cleavage) Ar O P Me O Ar R1 B(pin) CuL* X N R2 7 N Me Me Enantioselective Synthesis of Tertiary Alcohols and Amines: As illustrated in Scheme 2D, we are investigating the enantioselective Cu-catalyzed synthesis of tertiary allylic alcohols and amines. Treatment of catalytically generated enantioenriched copper-allyl with nitroso–arenes and diazene electrophiles furnishes tertiary alcohols and amines in high yield and enantioselectivity. Alkoxy–amine intermediates undergo rapid N– O cleavage with a second equivalent of nitroso-arene to yield alcohols 4 and 5 in high yield and enantioselectivity. Reactions are promoted by chiral phosphoramidite-copper complexes that lead to >98:2 a:g, >91:9 e.r. In addition, the N–O intermediates can be intercepted prior to N–O cleavage. Stereoselective Defluoro-Allyl addition Methods and Reactions with Boryl-Enamines: We have harnessed the reactivity afforded by boron-stabilized carbanions to establish a method for the site- and stereoselective C– C couplings of aryl–CF3 and –CF2 groups with allylic nucleophiles (e.g., 10 and 12). Moreover, we have discovered a powerful method for the synthesis of borylated enamines (Scheme 2). These are versatile intermediates that are typically difficult to prepare for a range of amines but provide an avenue for amine incorporation through various coupling reactions. Examples of enantioselective transformations and reaction that generate stereocenters include, enantioselective conjugate addition (15), three-component of formamides into a-amino nitriles (16) (amino acid precursors), and efficient Pd-catalyzed cross-coupling followed by reduction to afford chiral trifluoromethyl alcohols (17). These C-C bond forming reactions are being optimized and their enantioselective variants will be evaluated. Scheme 2. Representative Examples of Lewis Base Promoted Site- and Stereoselective Defluoro–Allyl Additions of Trifluoromethyl- and Difluoromethylene-Arenes: · Diastereoselective Crotylation: Synthesis of Tertiary–Alkyl Fluorine Stereocenters · Diastereoselective Sequential Defluoro-Allyl Additions to Trifluoromethyl–Arenes: F F B(pin) 1) 10 mol % CsF, 18-Cr-6, allyl-SiMe3 F F CF3 DME, 80 °C, 18 h + CH[B(pin)]2 LiOMe (1.5 equiv) B(pin) N Me Me 10 9 N Ph N 2) LiOMe (1.5 equiv), allyl-[B(pin)]2 Me nBu 8 DME, 80 °C, 18 h Ph N DME, 80 °C, 18 h (1.0 equiv.) (1.5 equiv.) 73% yield 11 12 r.r. = >95:5 ? :? 7:1 dr 43% yield (2 steps), 3:1 d.r. F. Representative Synthesis and Reactivity of Boryl Enamines and Amine Substituted Allyl Boronates: ■ Synthetic Approach: R O B(pin) Li–CH[B(pin)]2 N N R 14 13 Boryl Enamine Amides – Ubiquitous (Versatile Intermediate) Functional Group · Enantioselective 1,4-Addition: · Three-Component Coupling: · Trifluoromethyl Acetone Coupling: O –hydrocyanationPh –Hydrolyysis and reduction O MeO MeO N Ph OH N OtBu C CF3 H N 15 Ph 16 17 85% yield, >20:1 E/Z, 96:4 e.r. 33% yield (3 steps) 89% yield (2 steps) B. Justification of Need: Replacement for a broken SFC instrument and critical need for efficient chiral SFC analysis of difficult to separate enantiomers of alcohols, amines, and fluorine-containing stereocenters. A critical aspect of catalytic stereoselective methods development is the need to rapidly determine the enantioselectivity of novel chiral compounds prepared for each single reaction. Such requirement relies almost exclusively on the use chiral separation methods for determining accurate enantiomeric ratios (e.r.) and gauging reaction effectiveness. This challenging feature is compounded by the fact that most of the compounds have never been synthesized before. Consequently, there is a crucial need for the ability to rapidly and accurately determine e.r.s for chiral compounds that result from reaction optimization (e.g., catalyst, chiral ligand, base, solvent, temp., etc.), especially those that contain >1 stereocenter. These data are essential for developing the most efficient and stereoselective transformations that allow synthetic chemists to prepare key biologically relevant compounds in high enantioselectivity (>95:5 e.r.). Supercritical fluid chromatography is a mainstay for such analyses. We previously had a working SFC instrument for chiral separation and e.r. determination. This instrument is 8 years old and is now broken beyond repair due to the large volume of use it received, and its aging components. It should be noted, the SFC in my laboratory was the only working SFC in the department of chemistry for the last two years, and was utilized by other organic groups (e.g., Profs Johnson, Alexanian, Nicewicz, and Aubé) whose instruments were not working or whom do not have a SFC but required its capabilities. At present we are limited to evaluating the enantiomeric ratio by high performance liquid chromatography (HPLC) analysis. Chiral HPLC analysis is time consuming, wasteful, and problematic, particularly for amines (see Scheme 1) and diastereomeric mixtures (i.e., >1 stereocenter). The inability to swiftly analyze material can delay a project by weeks, or months, depending on the functional groups. Chiral SFC is critical to analyzing the chiral boron-containing alcohols and amines generated in this program: We have encountered many examples during our studies of catalytic enantioselective additions of allyl nucleophiles to electrophiles where enantiomer separation and e.r. determination is feasible and more efficient by chiral SFC. For example, as illustrated in Scheme 3 the enantiomers of tertiary Scheme 3. Example of Chiral SFC versus HPLC: alcohol 4 could not be successfully separated by HPLC with many Enantiomeric Ratio Determination Tertiary Alcohol 4 OH different columns and solvent combinations in order to obtain an Me2N N 10 mol% CuOtBu accurate e.r. In contrast, chiral SFC with a super critical CO2 mobile O 12 mol% L1 Me B(pin) Me CD3OD (1.05 equiv) 4 phase proved successful for achieving clean peak separation. The [(pin)B]2HC 72% yield, Bu THF, -60 °C, 16 h 91:9 e.r. necessity to procure chromatograms with baseline peak separation · Attempted unsuccessful e.r. analysis of 4 by HPLC: can cost days, if not weeks of time. Now that our SFC has recently broken and is unrepairable, analysis of reaction enantioselectivity takes longer and is often unreliable. Loss of such an important analysis method could not be predicted in advance, but we anticipate · Rapid e.r. analysis of alcohol 4 by SFC instrument the need to maintain such analysis for the duration of this MIRA grant. The requested funds will provide chiral SFC instrumentation that will allow us to reliably and rapidly develop new highly enantioselective reactions for the generation of stereochemically complex, single enantiomer pharmaceuticals important to improving human health. Instrument Usage & Anticipated Future Reoccurring Costs: Five graduates, and one undergraduate researcher working under the support of this MIRA grant, are all involved in stereoselective synthesis projects and require e.r. determination on a regular basis. Based on our 8 years of prior experience with chiral SFC instruments, reoccurring future costs associated with equipment maintenance and upkeep will be able to be sufficiently covered under the current grant funding to ensure instrument longevity of ³8 years.